Metabolic Studies of Mouse Models of Obesity and Diabetes

The following projects have been supported by Mouse Metabolism Core Laboratory in FY 2015 1. DK031131 Role of muscarinic acetylcholine receptors in glucose and energy homeostasis Principal Investigator: Jurgen Wess (LBC, NIDDK) 2. DK043313 Role of the Gnas Gene in Metabolic Regulation Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 3. DK043315 Role of Gs-alpha in central regulation of energy and glucose metabolism Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 4. DK043316 Role of Gs-alpha in regulation of adipose tissue growth and function Principal Investigator: Lee S. Weinstein (MDB, NIDDK) 5. DK025102 Erythropoietin receptor and glucose metabolism Principal Investigator: Constance T Noguchi (MCB, NIDDK) 6. DK075004 Identification of novel molecules and pathways that modulate adipogenesis Principal Investigator: Elisabetta Mueller (GDDB, NIDDK) 7. DK031117-27 Development Of Drugs Acting At Adenosine Receptors Principal Investigator: Kenneth A Jacobson (MR, NIDDK) 8. DK060101 Targeted disruption the enzymes of O-GlcNAc cycling: animal models of disease Principal Investigator: John A Hanover (LCMB, NIDDK) 9. DK075057 DEOB Physiology and Pharmacology of BRS-3 (Bombesin Receptor Subtype-3) Principal Investigator: Marc L. Reitman (DEOB, NIDDK) 10. DK075063 DEOB What can body temperature tell us about energy homeostasis? Principal Investigator: Mark L. Reitman (DEOB, NIDDK) 11. DK075064 DEOB Role of brown adipose tissue (BAT) in energy balance Principal Investigator: Mark L. Reitman (DEOB, NIDDK) 12. DK061000 LGP Genetic Approaches to Understanding Organ Development and Function Principal Investigator: Lothar Hennighausen (LGP, NIDDK) 13. DK056018-06 Sphingolipid Biology and Regulation of Metabolism Principal Investigator: Richard L Proia (GDDB, NIDDK) 14. DK056014 Mouse Models of Novel Sphingolipid Biology and Disease Principal Investigator: Richard L Proia (GDDB, NIDDK) 15. DK075035 Genes associated with endocrine tumorigenesis Principal Investigator: Sunita K Agarwal (MDB, NIDDK) 16. DK055106 Transforming growth factor - beta superfamily signaling in diabetes and obesity Principal Investigator: Sushil Rane (DEOB, NIDDK) 17. DK047052 Clinical utility of leptin therapy in syndromic forms of insulin resistance. Principal Investigator: Rebecca J Brown, Phillip Gorden (DEOB, NIDDK) 18. DK075096-02 Does the Drd2 receptor play a causal role in obesity? Principal Investigator: Alexxai V. Kravitz (DEOB, NIDDK) 19. HL006004-07 Olfactomedin 4 is a key regulator of colon cancer progression Principal Investigator: Griffin P Rodgers (MCHB, NHLBI) 20. BC005708 Xenobiotic receptors Principal Investigator: Frank J Gonzalez (LM, NCI) 21. HD000641 Physiology, psychology, and genetics of obesity Principal Investigator: Jack Adam Yanovski (UGO, NICHD) 22. HD000642 Molecular Genetics of Adrenocortical Tumors And Related Disorders Principal Investigator: Constantine A Stratakis (PDEG, NICHD)